Assessment of Effectiveness of IMPT vs. IMRT through Phase II Randomized Clinical Trials

The primary goal of this project is to evaluate, through phase II randomized clinical trials for brain, head and neck, lung and liver cancers, the effectiveness of intensity-modulated proton therapy (IMPT) relative to intensity-modulated photon radiotherapy (commonly referred to as IMRT). The overall long-term goal and the expected outcome ofthe proposed research is the development of proton therapy strategies which maximally exploit the physical as well as biological properties of protons to improve clinical outcomes. The common theme ofthe proposed trials is acute and late toxicity reduction, quality of life (QOL) improvement and, potentially, improvement in local control and survival. This project supports the mission ofthe NCI to improve the treatment and continuing care of cancer patients.

Public health relevance
This research aims to improve radiation treatment for cancer patients by improving our ability to direct the radiation at the tumor to spare adjacent normal tissue by using protons (charged particles) with intensity-modulated proton therapy. This can potentially improve cancer cure rates, reduce side effects, or both, depending on the clinical scenario. With an increasing number of proton centers in the United States and abroad, the research in this program is increasingly important for public health.